Comparative Biomedical Scientist Training Program

The project is a constituent of the NIH Graduate Partnership Program and serves to coordinate the doctoral research training and the university-NIH interface. The project goals became more widely recognized within academic veterinary medicine as new university partners were recruited. The academic community recognized limitations in workforce size and access to resources remained perennial challenges to greater progress in academic veterinary medicine and engagement between human and veterinary medicine (One Health). Ongoing resource constraints occur in part due to limited public understanding of the role veterinarians play in improving human health. One Health interactions, particularly through interdisciplinary collaborations in biomedical research, present constructive opportunities to inform resource policies and advance health care. To this end, inter-institutional partnerships between individual veterinary medical education programs (VMEPs) and several National Institutes of Health (NIH) intramural research programs have created synergies beyond those provided by individual programs. In the NIH Comparative Biomedical Scientist Training Program (CBSTP), interdisciplinary cross-training of veterinarians consisting of specialty veterinary medicine coupled with training in human disease research leading to a PhD, occurs collaboratively on both VMEP and NIH campuses. Pre-doctoral veterinary student research opportunities have also been made available. Through the CBSTP, NIH investigators and national biomedical science policy makers gain access to veterinary perspective and expertise, while veterinarians obtain additional opportunities for NIH-funded research training. CBSTP Fellows serve as de facto ambassadors enhancing visibility for the profession while in residence at NIH, and subsequently through a variety of university, industry, and government research appointments, as graduates. Thus, the CBSTP represents an inter-institutional opportunity that not only addresses critical needs for veterinarian-scientists in the biomedical workforce, but also simultaneously exposes national policy makers to veterinarian-scientists' specialized training, leading to more effective realization of One Health goals to benefit human and animal health. The Laboratory of Cancer Biology and Genetics, Molecular Pathology Unit (MPU) staff has responsibility for training and mentoring trainees. Trainees undertake pre-dissertation research within the MPU for which they receive university graduate course credit applicable for earning the Ph.D. degree as comparative biomedical scientists. The veterinary pathologists undertaking research training integrate pathology into the range of intramural research. Most recent program graduates finished PhD degree programs in the role of p53 in senescence of neural cells in brain following radiation treatment, therapy for multiple myeloma and the role of dopamine receptors in lung cancer. The program builds upon an interdisciplinary and comparative orientation to problems in biomedical science. Program and trainee accomplishments for fiscal year 2021 include: Presently there are 10 comparative biomedical scientists-in-training, supported by multiple NIH collaborating institutes. No fellows have completed their PhD degrees since the previous annual report. The summer internship program was not held this year due to the pandemic. The program completed a re-competition of its university partners through a national search with open competition. 5 university veterinary graduate programs were selected to continue the program. Recruiting and training is underway within the new Graduate partnership consortium.